Core C: Data Management and Biostatistics

ABSTRACT
This Data Management and Biostatistics Core (DBC) is designed to provide high-quality data management
infrastructure and statistical support, while using innovation and creativity to improve the delivery of our core
functions to investigators. The overarching goal for the PPG is to integrate basic science and clinical resources
to investigate the clinical, imaging, molecular, and neuropathological features of FTD. Historically, this PPG
has used sophisticated approaches to phenotyping patients, linking clinical signs and symptoms back to
neuroanatomic, genetic, and proteomic signatures to improve early and accurate diagnosis of FTD. Thus, the
DMB Core for this PPG has a particular mandate to support and facilitate our researchers' ability to link the
complex, multilevel data we collect, and to approach that data with appropriately sophisticated
recommendations for research design and analytic methods. At the center of the PPG is a comprehensive
database built using the LAVA platform, a data management solution specifically designed at UCSF for use by
integrative clinical research centers. It provides support for administrative, clinical and research procedures for
central cores and affiliated projects that share common patient cohorts and assessment protocols. Since the
last renewal of this PPG, we have also developed a suite of browser-based tools designed to work with MAC
data and help solve the problems posed by the complex, multidimensional data generated across PPG
projects and cores. This platform, called the KNECT system (Knowledge Network Core Technology),
comprises both single-patient data integration and normative interpretation across clinical, imaging, and
genetic modalities, and rapid data linking, analysis, and visualization of aggregate patient data, with tools for
combining phenotypic and genetic data with structural and resting-state functional MRI data. Finally, this core
is designed to provide integrated research design and biostatistical consultation to PPG personnel, guiding
researchers to approach similar problems in a consistent manner across projects and cores using the highest
quality and most reliable statistical approaches. Thus, the aims of this core are: AIM 1: To develop and
maintain centralized, integrated data management systems and procedures that ensure the accuracy,
availability, and confidentiality of administrative, clinical, and research data from PPG cores and projects. AIM
2: To provide PPG researchers with data integration and analysis tools supporting their ability to effectively
combine and utilize data across cores and projects to accelerate discovery. AIM 3: To provide high-quality
biostatistical consultation to all PPG cores and projects in order to systematically unify and focus research
design and statistical analysis. AIM 4: To promote research methods integration and collaboration among PPG
cores, projects, and related research protocols through efficient data sharing, coordinated data analysis plans,
and regular meetings to discuss the research process and data interpretation.

Public health relevance
NARRATIVE The overarching goal for the PPG is to integrate basic science and clinical resources to investigate the clinical, imaging, molecular, and neuropathological features of FTD. This Data Management and Biostatistics Core is designed to provide high-quality data management infrastructure and statistical support, while using innovation and creativity to improve the delivery of our core functions to investigators. We support our researchers' ability to gather and link the complex, multilevel patient data, and to approach that data with appropriately sophisticated research design and biostatistical methods.